Global Analysis of Arsenic-Induced Gene Expression Profi

We have employed two genome technologies in Saccharomyces cerevisiae to determine the cellular impact and possible mechanisms involved in arsenic toxicity and carcinogenicity. By combining transcript profiling with the screening of a comprehensive panel of bar-coded mutant strains, we have identified the genes and pathways most affected by this metalloid.